Development of osmoregulation disruptors for tick control

Project Summary
Ticks are obligatory ectoparasites that feed on vertebrates and transmit pathogens during blood feeding, causing
health problems globally in animals and humans. Ticks transmit a wide variety of pathogens, including bacteria (e.g.,
rickettsia), protozoa, and viruses, and directly damage their hosts. A most significant tick physiology that allows ticks
survive in the field is maintaining water balance throughout the lifetime including the off-host periods. The
osmoregulatory mechanisms in Metastriata ticks include: 1) directly drinking water through the gut and the salivary
glands, 2) losing large amounts of water through dermal secretion, and 3) losing water with excretion of metabolic wastes.
The central dogma in this proposal is using the tick water drinking behavior as a route of delivering toxic agents to
disrupt the osmoregulatory pathway, which is a vulnerable toxicological target in off-host ticks. Ample preliminary
data provides the proof of the concept. Tick deaths could be induced by voluntary drinking of phosphate-rich iso-osmotic
solutions and also by thermally induced exhaustive dermal secretion. The aims of the proposals are to develop the tick-
specific osmoregulation disruptor (Aim 1) and to investigate the physiology of water loss through tick dermal secretion
(Aim 2). In the Aim 1, we will study the physiology of the inorganic phosphate metabolism and phosphate-mediated
electrochemical imbalance in the excretory system, which function as a significant osmoregulatory disruptor. Aim2 will
uncover the mechanisms of dermal secretion including serotonin-mediated regulation and ion transport mechanisms in the
dermal glands, which is a unique organ associated with a loss of large amount (~300 nL) of fluid within a second upon
thermal/mechanical stimulation. The strategy using an osmoregulatory disruptor fits well in the hot and dry season in the
Midwest and Southwest area of the U.S. where numerous Metastriata ticks, Amblyomma, Dermacentor, Rhipicephalus,
and Haemaphysalis, and the pathogen transmission have been reported. The current proposal is to expand the knowledge
of the target physiology, linking to the long-term goal in the development of environmentally compatible tick control
measures.

Public health relevance
Project Narrative Ticks are obligatory ectoparasites that feed on vertebrates and transmit pathogens during blood feeding, causing health problems globally in animals and humans. This proposal aims to develop tick control measures using the tick water drinking behavior as a route for delivering toxic agents for the disruption of the osmoregulatory pathway, which is a vulnerable toxicological target in off-host ticks. The knowledge obtained in this proposal will provide the foundation for the long-term goal of the development of a tick-specific toxic formula delivered for field application through the tick drinking behavior.